Mechanisms of immune homeostasis and regulation of intraocular inflammation

Allogeneic hematopoietic cell transplantation (HCT) is inaccessible to many patients with hematologic malignancies for lack of HLA-matched donors. Although nearly all patients have HLA haploidentical donors, HLA-haploidentical HCT still results in high mortality due to prohibitive rates of severe Graft-Versus-Host Disease (GVHD). Increase of proinflammatory cytokines and reduced levels of regulatory B cells (Bregs) drive GVHD development. We We investigated whether ex-vivo generated i35-Breg cells can suppress GVHD in mice. We have been able to suppress GVHD for more than 3 months in more than 90% of mice with GVHD that receive i35-Breg therapy.
-